Towards a Comprehensive, Spatiotemporal Roadmap of Cancer Metastasis

PROJECT SUMMARY
Cancer metastasis, which accounts for 8 million deaths worldwide annually, is a multistep process that includes
the emergence of metastatic subclones in primary tumors, dissemination and survival in circulation, seeding and
colonization at distant sites. Deciphering the evolutionary dynamics, the spatial context, and the molecular nature
of each step during metastasis is critical to understanding this lethal phase of tumor evolution, and to potentially
develop effective therapeutic strategies. However, it remains challenging to directly study these events due to
their stochastic and rare occurrence over long time frames, diverse interactions within the microenvironment,
and transient shifts in cellular plasticity. Among the most highly metastatic and lethal cancer types, small cell
lung cancer (SCLC) is a neuroendocrine subtype of lung cancer with a median survival of only 7– 12 months,
which has not improved over the past 30 years. Despite its clinical importance, SCLC metastasis remains
underexplored due to the paucity of clinical metastatic samples, which raised several fundamental questions:
what is the origin and evolutionary dynamics of SCLC metastases? Whether and how does the microenvironment
contribute to metastasis? Whether and how key intermediate cell states influence evolutionary fate decisions?
Our overarching goal is to elucidate the cell intrinsic and extrinsic mechanisms underlying SCLC metastasis,
and ultimately develop a comprehensive, spatiotemporally-resolved roadmap of SCLC metastasis using a
genetically engineered mouse model of SCLC. To achieve this goal, we will develop a suite of cutting-edge
technologies that will overcome substantial technical hurdles that have thus far precluded progress, and will
allow us to establish a comprehensive, spatiotemporally-resolved lineage tracing platform capable of recording
the entire course of SCLC metastasis. Specifically, we will 1) map the evolutionary dynamics and trajectories of
SCLC metastasis by the generation and analysis of an evolving lineage tracing mouse model of SCLC, 2) dissect
the spatial context and cellular composition of the pro-metastatic niche by creating a high resolution spatial-
lineage platform, and 3) investigate transient cell state changes during metastasis through signal recording. Our
systematic effort will culminate in the generation of a comprehensive blueprint of SCLC metastatic progression.
This blueprint will integrate the evolutionary dynamics, the spatial and microenvironmental context, and the
molecular features and gene expression dynamics underlying SCLC metastasis, offering significant insights for
future functional dissection and therapeutic development. The technical advances and biological discoveries
generated here will transform our conceptual understanding of cancer metastasis, create cutting-edge
technologies for dissecting the mechanisms of tumor evolution, and potentially reveal novel ways for
stage/gene/environment-specific therapeutic strategies to limit SCLC metastatic spread and target metastases,
and therefore is ideal for the DP2 mechanism. More broadly, our work will create a general platform for studying
the progression of many cancer types, enabling a holistic understanding of tumor evolution.

Public health relevance
PROJECT NARRATIVE Cancer metastasis accounts for more than 8 million deaths worldwide annually, however, our understanding of the mechanisms underlying metastasis remains incomplete. This proposal aims to develop a comprehensive, spatiotemporally-resolved roadmap of small cell lung cancer metastasis by developing and applying new technologies that integrate single-cell lineage tracing, spatial transcriptomics, and transcriptional recording. A comprehensive understanding of these mechanisms will reveal key molecular changes underlying each step of metastatic progression, and could potentially inform rational therapeutic approaches.